Promoting wellness and resiliency

This administrative supplement proposal will allow us to add an important new mental health and resiliency initiative that will serve our MARC and IMSD undergraduate students as well as any undergraduates planning to obtain an advanced degree and our current graduate students. Our initiative, which will be fully integrated into our MARC/IMSD curriculum, seeks to equip students with mental health resources produced in part by current SDSU graduate students to destigmatize the need for mental health support. Students will attend workshops by experts on the specific mental health challenges of graduate students and on tools for resiliency, and by former MARC and IMSD students who have completed their graduate work. Survey data from MARC, IMSD, and current graduate students will guide the generation of short videos on mental health and resiliency created by and starring SDSU graduate students under the careful direction of SDSU campus leaders in the areas of Clinical Psychology, Counseling and Psychological Services, and Student Success/Advancement.

Public health relevance
MARC Project Narrative San Diego State University proposes to select 10 Maximizing Access to Research Career (MARC) honors scholars and provide them with a strong academic curriculum, workshops, mindset training, virtual mentoring through the NRMN website, and graduate school preparation centered on faculty mentored research experiences. These opportunities will allow our scholars to develop research skills and to contribute to manuscripts leading to publications and presentations at professional conferences. We will offer a Pre-MARC program and use evidence based evaluation data to improve and institutionalize more programs to enhance student success and diversity in STEM disciplines. Through these efforts will be able to maintain an 80%-90% rate of matriculation to Ph.D. programs in STEM disciplines.